Sweet Blood: Diabetes and the Changing Nature of Modern Health

An interdisciplinary historical study of a global health crisis, focused primarily on North America,
Sweet Blood traces how today’s diabetes epidemic grows from changing relationships with nature over the
past 150 years, and how those relationships create or reinforce social inequities that further drive illness,
comorbidities, and social differences.
A NLM-NIH grant will provide essential funding to assist remaining research as well as time away
from the classroom for a sabbatical to finish the book manuscript. As a scholar-teacher at a selective
residential liberal arts college, the twinned gifts of research and leave support are vital to maintain
scholarly productivity. My additional training in epidemiology will also allow me to complete a project
applicable to public health.
Sweet Blood fills a significant gap in our knowledge of diabetes by analyzing how an expanded and
historicized understanding of “environment” reveals the origins and persistence of social determinants of ill
health. The project draws upon scholarship in four distinct academic fields. First, environmental history,
which demonstrates how microbes, animals, and other forces of nature act upon history by reinforcing or
limiting human agency. Second, the history of medicine, which connects race, gender, and class to
reconsider how illnesses and identities entwine. Third, science and technology studies, which emphasizes
how contests over expertise are shaped by engagement with material nature and cultural norms. Finally,
social epidemiology, which pools diverse methodologies to evaluate the origins and distribution of disease
and health inequities. “Sweet Blood” connects these fields through extensive archival and primary source
research to offer an important and timely reinterpretation of diabetes.
Sweet Blood thus examines diabetes on several interlocking levels. It is a story of diabetes as
material reality, of its increase and spread over the course of the twentieth century. It is a story of the
creation of knowledge about diabetes to aid diagnosis, promote prevention, and assist treatment from
clinical findings to entire populations. And it is a story of diabetes as a cultural symbol for ideas and
practices about health, human behavior, and the environment that often generate inequalities. Sweet
Blood blends these stories to reframe diabetes as a series of environmental relationships that change over
time and space. This project will result in a book (under contract) with Yale University Press.

Public health relevance
The proposed research project is relevant to public health because it is the first book-length interdisciplinary historical study of the environmental origins and consequences of a major chronic illness. Sweet Blood: Diabetes and the Changing Nature of Modern Health will benefit biomedical scientists, clinicians, historians of medicine, and public health experts by shedding new light on the deep historical antecedents to current social determinants of health. The project is germane to the Public Health Service because it explains how shifting relationships with mutable ecologies create or reinforce inequalities between individuals and populations, further driving diabetes prevalence alongside socioeconomic disparities.